Caveolin-1 contributes to the long-term function and structure of the neurovascular unit after juvenile concussion

Summary Project
The majority of traumatic brain injury (TBI) is mild in nature but is known to elicit long-term consequences,
including emergence of dementia and accelerated age-related declines. The highest-at-risk group are children
whose brains are still undergoing development. This proposal will investigate the short- and long-term, cellular
and molecular changes in the brain following juvenile mTBI (jmTBI) with the goal to intelligently develop new
therapeutic options. Caveolin-1 (Cav-1) is an abundant structural protein involved in caveolae formation and
cell signaling which is expressed in cerebral endothelial cells and in astrocytes, key components of the
neurovascular unit (NVU). Recent development of a compound to target the Caveolin Scaffolding Domain
(CSD), a complex that compartmentalizes structural proteins (e.g. claudin-5) and signaling molecules (e.g.
eNOS), has provided tools to explore the role of Cav-1 in acquired neurological disease. After stroke, we
found increased Cav-1 expression and Cav-AP treatment was beneficial for post-injury recovery. However,
consensus is lacking whether Cav-1 exhibits beneficial or deleterious actions in other acquired brain
disorders, such as jmTBI. Our model of jmTBI exhibits accelerated loss of cognition associated with
decreased vascular function over their lifespan. We therefore will test the hypothesis that dysfunction in
neurovascular coupling after jmTBI can be prevented by modulation of Cav-1 signaling, blunting accelerated
hippocampal and cortical aging. Aim 1 will demonstrate that Cav-1 is critical for maintaining NVU functionality.
We examine the role of vascular Cav-1 in male & female jmTBI mice in normal (WT), vascular Cav-1 deficient
mice (Cav-1-/-) and in Cav-AP treated mice. We believe that jmTBI mice treated with Cav-AP will exhibit
vascular recovery, whereas the loss of Cav-1 will worsen NVU outcomes. In Aim 2 we will examine how Cav-
1 in reactive astrocyte processes influences progression of jmTBI. We will modulate Cav-1 expression directly
in astrocytes by injecting AAV-GFAP-Cav-1-shRNA and AAV-GFAP-synCav-1 in control and injured mice and
quantify vascular recovery and behavioral outcomes. Increased astrocytic Cav-1 will be associated with
improved NVU properties and cognitive outcomes. In Aim 3 we will examine male & female mice over their
lifespan and examining if increased Cav-1 blunts accelerated brain aging that we have observed after jmTBI.
We will assess behavioral, neuroimaging and histological outcomes. jmTBI mice treated with Cav-AP will
exhibit improved outcomes related to enhanced NVU function and integrity. In sum, the proposed research
is a critical first step in examining the role of Cav-1 in jmTBI and if therapeutic intervention can lead to
enhanced NVU stability and function and thereby moderate accelerated aging.

Public health relevance
Project Narrative Caveolin-1 (Cav-1) is present in constituents of the neurovascular unit (NVU), neurons, astrocytes and in endothelial cells (EC). Cav-1 is poorly defined in acquired neurological diseases and this project is focused on defining the role of Cav-1 in EC and reactive astrocytes in our mouse model of juvenile mild traumatic brain injury (jmTBI). The beneficial or deleterious functions of Cav-1 expression will be challenged with genetic and new pharmacological approaches to assess the accelerated lifespan aging we have observed in jmTBI. The long-term goal is to provide a novel pharmacological intervention for juvenile TBI patients where no viable treatment options currently exist.